A developmental engineering toolbox for controlled epithelial morphogenesis

PROJECT SUMMARY
The goal of this proposal is to contribute new engineering technologies that gain control over cell
collective phenomena responsible for driving epithelial organogenesis in vivo. Tightly packed epithelial
sheets and tubules are crucial to the function of a diverse group of organs including the lung, kidney, mammary
gland, and prostate. Congenital defects and adult diseases such as cancer that occur during the development
and maintenance of such organs are prevalent, creating a significant disease burden. This has driven
innovation in tissue engineering, which aims to create artificial tissues that serve as disease and therapy
screening models. However, modern tissue engineering approaches fail to harness several hallmarks of
epithelial organ formation, limiting the complexity of synthetic tissues and creating an urgent need for
innovation. Rather than being assembled from constituent cells all at once, processes like branching
morphogenesis progressively ramify, sculpt, and pack together functional tubule structures in vivo. The long-
term goal of the Hughes lab is to study and engineer missing tissue-building principles at play in organ
development to fill ongoing gaps in tissue engineering. This goal builds upon ongoing work in the Hughes lab
from the previous period of R35 funding beginning in 2019. This includes 1) precision ssDNA-based cell and
tissue interface micropatterning technologies to 2) control the size, cell composition, and differentiation
trajectory of epithelial organoids; 3) shape-changing ‘kinomorph’ tissue scaffolds for guiding tissue building
behaviors in cell collectives; and 4) mechanically manipulating epithelial progenitor niche regulation. Now our
overall objectives are to further advance three research visions across kidney and lung model systems. We
firstly seek to map the relationship between tissue mechanics and cell-cell signaling on epithelial
morphogenesis via orthogonal optogenetic ‘handles’. This will allow us to better control organoid cell
composition. We secondly seek to gain control over epithelial tubule shape and elongation by engineering
anisotropic collective cell forces through planar cell polarity pathways. We thirdly seek to combine tubule
construction and microfluidics approaches to engineer axial tubule polarity. Together these missing tissue-
building modules will contribute innovative enabling technologies for ‘higher-order’ tissue construction relevant
to the general medical sciences. The Hughes lab is uniquely suited to tackle our research vision due to our
expertise in stem cell engineering and optogenetics, live imaging, microfluidics, and advanced tissue assembly
strategies. We expect our proposed contributions to have significant positive impact in the areas of
fundamental biological discovery, tissue construction, and drug target screening.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will study and engineer new principles of organ development toward building functional human tissue models. Once these new principles are applied, they will spur significant advances in tissue engineering. The proposed research is especially relevant to one of the NIH’s 2021-2025 strategic plan goals, which specifically highlights new cell engineering and bioengineering approaches to building human tissues for disease modeling that will contribute to reducing illness and disability.